Functional Characterization of ABCA3 Genomic Variants

PROJECT SUMMARY
Rare, usually private, biallelic pathogenic variants in the ATP binding cassette transporter A3 gene (ABCA3)
are the most common monogenic cause of neonatal respiratory failure in term infants and childhood interstitial
lung disease (chILD). ABCA3 transports phospholipids required for surfactant assembly and function across
the lamellar body membrane in alveolar type 2 cells (AT2s). Broadly, ABCA3 pathogenic missense variants
encode mutant proteins that (1) disrupt intracellular trafficking or (2) impair ATP-mediated, phospholipid
transport into the lamellar body. However, the mechanism of ABCA3 variant-encoded disruption is not reliably
predicted by location in the gene or protein and does not reliably correlate with associated heterogeneous
lung disease phenotypes. Lack of neonatal symptoms among many children with chILD due to biallelic ABCA3
variants suggests that variant-specific mechanisms chronically disrupt AT2 cell metabolism and trigger
differing lung disease phenotypes. Pathogenic variants in SFTPC, which encodes surfactant protein-C,
activate intracellular stress and degradation pathways. However, there are limited data regarding activation
of cell stress and proteostasis pathways by ABCA3 variants. Pharmacologic therapies for ABCA3 deficiency
remain limited, non-specific, and unpredictably effective, and the 5-year survival for lung transplantation
remains stagnant at ~50%. Variant-specific modulator therapies like those developed for individuals with
cystic fibrosis due to biallelic variants in CFTR, which encodes another ATP binding cassette transport protein
(also known as ABCC7), are needed.
Recently, we observed similar cell-based features when ABCA3 pathogenic variants were expressed
in either human induced pluripotent stem cell derived AT2 cells (iAT2s) or human pulmonary epithelial cell
lines (A549). Further, iAT2 cells that express ABCA3 pathogenic variants demonstrate upregulation of
pro-inflammatory pathways and reduced progenitor potential, consistent with an epithelial-intrinsic aberrant
phenotype. For efficient characterization of cell stress and proteostasis pathways and for efficient high
throughput screening of FDA-approved compounds that rescue ABCA3-encoded disruption, we will use A549
cell lines that stably express individual ABCA3 pathogenic variants. For confirmation of pharmacologic rescue
of ABCA3 mutant AT2 cell phenotype, surfactant phospholipid composition, and lamellar body phenotype by
screen-identified, FDA-approved compounds, we will use isogenic iAT2 cells edited to express the same
ABCA3 variants. These specific aims will test the hypothesis that variant-encoded disruption of ABCA3
trafficking or phospholipid transport activates pathogenic cell stress and proteostasis pathways and can be
corrected with FDA-approved compounds.

Public health relevance
PROJECT NARRATIVE Mutations in the ABCA3 gene are the most common genetic cause of childhood interstitial lung disease (chILD) among infants and children. As medical treatments remain limited, affected patients may require lung transplantation for survival. We will use human lung cell lines to determine how specific ABCA3 mutations cause chILD and to discover FDA-approved medications to treat infants and children with chILD due to ABCA3 mutations.